Microbiota-Immune Interactions in CTLA-4 Antibody Blockade-Induced Colitis

Abstract
Monoclonal antibodies targeting CTLA-4, PD-1, and PD-L1 are widely used to promote anti-tumor
immune responses in a range of human cancers, but can also lead to inflammatory toxicities,
collectively referred to as immune-related adverse events (irAEs). Colitis is a common and severe
irAE which can lead to treatment discontinuation, particularly in patients receiving anti-CTLA-4
antibodies alone or in combination with PD-1 blockade. Intestinal inflammation triggered by CTLA-
4 antibodies typically involves the colon and is characterized by the accumulation of CD4+ T
lymphocytes and neutrophils in the intestinal tissue. Analyses of colitis-associated lymphocytes
of melanoma patients receiving CTLA-4 and PD-1 inhibitors have further implicated the
pathogenic contributions of tissue resident CD8+ T cells with cytotoxic features. However, the
role of the microbiota and the immune pathways critical for immune checkpoint blockade (ICB)
induced-colitis remain poorly understood. Our understanding of the immunological mechanisms
of ICB induced-colitis have been impeded by the lack of robust animal models of colitis caused
by immune checkpoint inhibitors. Laboratory mice are highly resistant to intestinal inflammation
following treatment with antibodies targeting immune checkpoints. We found that this limitation
can be overcome by using mice harboring the microbiota of wild-caught mice, referred to as wild
mouse microbiome-reconstituted (WildR) mice, which develop overt colitis following treatment
with anti-CTLA-4 antibodies. Intestinal inflammation is driven by unrestrained activation of IFN-
producing CD4+ T cells and depletion of peripherally induced regulatory T cells through Fc
receptor signaling. Accordingly, anti-CTLA-4 nanobodies that lack an Fc domain can promote
anti-tumor responses without triggering colitis. We hypothesize that bacterial symbionts present
in the WildR microbiota, but not conventionally raised specific pathogen-free (SPF) laboratory
mice, are required to trigger over colitis after ICB. We further hypothesize that specific members
of the WildR microbiota stimulate intestinal dendritic cells (DCs) to activate colitic antigen-specific
CD4+ T cells in mice depleted of RORγt+ pTregs in the presence of CTLA-4 blockade. In this grant
application, we propose three specific Aims to further understand how the WildR microbiota
trigger colitis after ICB.

Public health relevance
Narrative Immune checkpoint inhibitor blockade (ICB) with monoclonal antibodies against CTLA-4 and PD-1, is widely used to promote anti-tumor immune responses in a range of human cancers but can also lead to inflammatory toxicities. Colitis is a common and severe type of adverse which can lead to treatment discontinuation. Using a newly developed model of ICB-induced colitis, we propose studies to understand how the microbiota and intestinal immune cells trigger colitis after ICB.